UNC-Greensboro U-RISE: Engage, Sustain, and Prepare Future PhD Biomedical Scientists

SUMMARY
The University of North Carolina at Greensboro (UNCG) U-RISE will be a comprehensive undergraduate training
program that will directly contribute to increasing the percentage of underrepresented (UR) students pursuing
graduate studies in preparation for careers in the biomedical research workforce. The proposed U-RISE Fellows
program will leverage an array of activities designed to promote academic and social integration, knowledge and
skill development, support and motivation, and monitoring and advising. Our program will use merit- and need-
based criteria to select U-RISE Fellows from our large pool of academically talented UR students. The UNCG
U-RISE program will engage these Fellows in substantive research projects leading to comprehensive basic
laboratory and evaluation skills. A quality pool of research faculty is available to mentor Fellows and sponsor
their research projects. Our multidisciplinary program will sustain academic, professional, and social
development with enrichment strategies that include community building activities, co-curricular instruction, and
intensive research workshops and experiences. The ultimate goal of our program is to prepare Fellows for
success in PhD level training in biomedical sciences by ensuring competency in research fundamentals and
requisite professional and science communication, teamwork, and leadership skills. We will also prepare these
students by networking them into the existing community of underrepresented scientists, postdoctoral
researchers, graduate, and undergraduate students via participation in relevant societies and professional
meetings. A multidisciplinary environment is integrated throughout our program and reinforced in its academic
enhancement core. Effective interdisciplinary research teams are more likely when participants have broader
exposure and understanding of complementary disciplines. Community-engaged activities, historical hallmarks
of UNCG’s identity, will provide perspective on the translational and social impacts of biomedical research. The
support provided through this program will have substantial effects on UNC-Greensboro U-RISE: Engage,
Sustain, and Prepare Future PhD Biomedical Scientists Fellows as well as the UR student population in
general at UNCG.

Public health relevance
NARRATIVE The University of North Carolina at Greensboro U-RISE will be a comprehensive undergraduate training program that will directly contribute to increasing the percentage of underrepresented students pursuing graduate studies in preparation for careers in the biomedical research workforce. The program synchronizes faculty development, undergraduate research experiences, and curricular activities to create an inclusive environment previously shown to promote student success.